Architecture and function of condensates formed by ubiquitin-binding shuttle proteins and protein quality control components

PROJECT SUMMARY/ABSTRACT: Efficient and effective protein quality control (PQC) is essential to
proper cell function. Despite extensive research, mechanisms underlying PQC remain incompletely
understood. Consequently, development of new therapies to treat conditions with dysregulated PQC
such as proteinopathies and neurodegenerative disorders is impeded. This MIRA research program
targets the Ubiquitin (Ub)-mediated PQC pathways, and specifically Ub-containing biomolecular
condensates. These condensates are membraneless assemblies comprising Ub-binding shuttle proteins
(e.g., UBQLNs, Rad23s) that preferentially condense with specific types of polyUb chains and PQC
components; the condensates are involved in a wide range of physiological processes including stress
response, proteasomal degradation, autophagy, and immune system activation. My lab’s work is
grounded in the hypothesis that dysregulation of these condensates leads to Ub-containing inclusions
characteristic of proteinopathies and neurodegenerative disorders, and specifically amyotrophic lateral
sclerosis (ALS) and frontotemporal dementia. We recently determined that ALS-linked UBQLN2 forms
stress-induced biomolecular condensates in cells and that the full-length UBQLNs (1/2/4) all undergo
phase separation in vitro to form condensates under physiological conditions. Important to the premise
guiding our projects is the observation that interactions with polyUb chains (in length- and linkage-
dependent manners) tune conditions for condensate assembly and disassembly. We predict that other
PQC components further tune the assembly/disassembly and structure of these condensates. In this
five-year MIRA program, my lab will use molecular biophysics and cell biology-based approaches to
achieve a mechanistic understanding of how Ub-binding shuttle proteins (UBQLNs, Rad23s, DDIs)
regulate function of biomolecular condensates in stress response and PQC. Our preliminary data from
reconstitution experiments suggest that condensates drive distinct PQC outcomes (e.g., protecting
substrates from degradation or driving substrate degradation). We surmise that these different outcomes
stem from different conditions driving condensate formation and/or the varied molecular architectures of
condensates composed of differing compositions of shuttle proteins and ubiquitinated substrates. Our
projects will determine (1) the physiological functions of UBQLN condensate formation in cells under a
myriad of cell stress conditions, (2) the molecular rules by which polyUb chains modulate condensation
of shuttle proteins and PQC components (e.g., full proteasomes, deubiquitinases, ligases), and (3) the
emergent functions of shuttle protein PQC condensates in regulating substrate degradation, protection
from degradation, and substrate ubiquitination/deubiquitination. The results from these projects will
uncover the role of condensates in mediating PQC under physiological and stress conditions.

Public health relevance
PROJECT NARRATIVE: Nearly all proteins in our cells are covalently modified with ubiquitin chains at one time or another, and many of these chains are vital to forming membraneless compartments with liquid-like behavior. In this MIRA, we combine molecular and cellular approaches to determine how these compartments form and regulate functional outcomes such as protein degradation. These results will help us understand the molecular basis of the formation and function of these compartments in protein homeostasis and disease.